Identification of osteoclast endocrine and paracrine communications by systems genetics approaches

Bone resorption by osteoclasts plays a pivotal role in skeleton growth, homeostasis, and fracture repair. In
adults, bone health is ensured by bone remodeling in which bone resorption is coupled and balanced by bone
formation from osteoblasts. Therefore, the number and activities of osteoclasts are tightly regulated by systemic
hormones and paracrine factors in bone marrow microenvironment. Meanwhile, bone itself is increasingly
recognized as an endocrine organ which can modulate functions of other organs in whole-body physiology.
While the systemic functions of endocrine factors derived from osteoblasts and osteocytes such as FGF23 and
osteocalcin have been well established, the endocrine functions of osteoclast secreted proteins remain to be
uncovered. To identify and functionally annotate endocrine and paracrine circuits, we have developed a novel
systems genetic approach, termed Quantitative Endocrine Network Interaction Estimation (QENIE), that utilizes
natural variation in transcript levels across tissues in multiple ‘omics’ datasets to predict modes of endocrine
communication. Applying this approach to datasets in the hybrid mouse diversity panel (HMDP), a collection of
approximately 100 inbred strains of mice exhibiting substantial diversity of most clinical traits relevant to human
diseases, we have unraveled many known endocrine interactions as well as several novel tissue-tissue circuits.
In the preliminary study leading to this proposal, we have quantitatively measured the levels of proteins and
RNAs in precursor and mature osteoclasts by mass-spectrometry based proteomic and bulk RNA-seq.
Hundreds of secreted proteins in osteoclast lineage cells have been identified by these ‘omics’ studies. While
several osteoclast-derived coupling factors known to stimulate osteogenesis during bone remodeling are in the
list of osteoclast secreted proteins, the endocrine and paracrine functions of most of these newly identified
osteoclast secretory proteins are unknown. Based on our work and reports by others, we hypothesize that the
endocrine and paracrine communications of osteoclasts play an important role in whole body and bone
homeostasis under physiological and pathological conditions. To test our hypothesis, we will identify novel
endocrine and paracrine circuits of osteoclast lineage cells by the system genetics bioinformatic framework
QENIE (Aim 1) and experimentally validate and functionally assess these osteoclast-derived factors by in vitro
cell culture and co-culture models (Aim 2). Successful accomplishment of the proposed work in this application
will formulate new hypotheses to be tested using in vivo animal models and in human populations. The findings
from this project will not only greatly advance our knowledge in osteoclast biology but also uncover new
therapeutic targets to treat bone loss in bone and other organ diseases.

Public health relevance
PROJECT NARRATIVE The aberrant bone resorption by osteoclasts causes bone loss, destruction, and fractures in metabolic and inflammatory skeletal and joint diseases such as osteoporosis and rheumatoid arthritis, leading to major public health problems affecting millions of Americans. We plan to apply innovative techniques to identify novel interactions of osteoclasts with other tissues and organs in our body. The findings from this project will uncover new therapeutic targets to treat bone loss in bone and other organ diseases.